An immunocompetent platform for the characterization and discovery of novel therapeutics for hepatocellular carcinoma

Project Summary
Liver cancer is the fourth leading cause of cancer-related death in the world and mortality rates are rising,
which, in part, reflects historical drug development campaigns focused on single agent therapies (multi-
targeted kinase inhibitors and immunotherapy) that have limited efficacy in patients. Additionally, there are a
lack of targeted, personalized therapeutic options for this cancer type. Thus, there is an urgent need to identify
novel tailored therapeutic strategies. Recent advances in the therapeutic targeting of hepatocellular carcinoma
(HCC) have discovered superiority in efficacy for either small molecule inhibitors (for example, lenvatinib) or
biologics (for example, bevacizumab) used in combination with immunotherapy, though less than 30% of
patients respond to these new frontline therapies. A major gap in the field is the lack of appreciation for inter-
patient heterogeneity and a failure to identify drugs that (I) uniquely target driver-specific vulnerabilities, or (II)
improve immunotherapy. This proposal focuses on an unexplored strategy for therapy design in liver cancer,
which leverages the usage of in vivo CRISPR screens and a novel patient-derived ex vivo autologous tumor
organoid-T cell co-culture platform to provide new biological insight to mechanisms of drug potency on two
critical components of the tumor microenvironment (TME), and allow assessment of combination therapies for
the improvement of immunotherapy. I hypothesize that drug advancement in HCC, particularly in
combination with immunotherapy, is dependent on drug-mediated modulation of tumor-T cell
interactions. This hypothesis will be tested in two aims: (1) dissection of the mechanism of action of a novel
candidate drug, WNTinib, in immunologically tractable models of HCC using in vivo CRISPR screens, and (2)
identification of novel immunotherapy combinations for the personalized treatment of HCC. For Aim 1,
WNTinib’s key targets (or mechanism’s contributing to activity or resistance) will be investigated using two
separate genome-scale CRISPR sgRNA screening strategies: (I) transducing genetically-defined murine HCC
organoids transplanted orthotopically into immunocompetent and immunocompromised mice, and (II)
transducing T cells from OT-I;Cas9 and OT-II;Cas9 mice and transplanting them into tumor models expressing
the OVA-derived peptide SIINFEKL. Analyses done in the presence of WNTinib will identify WNTinib’s tumor
cell intrinsic, TME-dependent, and T cell-dependent targets or mechanisms. For Aim 2, I will use HCC patient
tumor biopsies to establish organoids and tumor infiltrating lymphocyte (TIL) cultures. This approach will allow
the study of tumor and T cells as separate components and in co-culture together. I will expand this platform to
include drug screening, alone or in combination with immunotherapy, using a panel of drugs representing
various stages of HCC clinical advancement. Results from this proposal will represent a major step forward for
the multidimensional understanding of drug usage in HCC, and how drugs may be used in combination with
immunotherapy to provide personalized care.

Public health relevance
Project Narrative The goal of this proposal is to fundamentally understand how drugs target liver cancer within the context of both tumor and T cells. To address this question, this research involves the specific investigation of a novel drug in animal models of hepatocellular carcinoma, as well as the usage of patient tumors for the creation of a platform to investigate how drugs may improve immunotherapy. Overall, this proposal will help rationalize, understand, and advance new personalized therapeutic options for the treatment of liver cancer.